Role of Nitric Oxide in Interstitial Cystitis

DESCRIPTION (provided by applicant): Painful bladder syndrome/Interstitial cystitis (PBS/IC) is a chronic painful condition of the urinary bladder in which there are no proven etiologies and no effective treatments that are able to ameliorate the symptoms, which include urinary frequency, urgency, nocturia and pain. There is a comparable disease in domestic cats termed feline interstitial cystitis (FIC), which demonstrates nearly all of the characteristics and symptoms of human PBS/IC. Cats with this naturally occurring disease, as opposed to acute injury/inflammation in rodent models, may permit more relevant studies of the pathophysiology of PBS/IC in humans. We have identified a number of abnormalities in the urothelium of FIC bladders including alterations in barrier function, proliferation and growth, and a heightened sensitivity/response to both chemical and physical stimuli. These may be a result of changes in intracellular Ca2+ release/sequestration and/or intracellular signaling pathways. There are also abnormalities in FIC bladder afferents including altered morphological/electrical properties, nerve firing and distribution of nerve fibers. Moreover, we also have evidence of long-term alterations in FIC spinal cord glial cell morphology and function in regions of pelvic afferent input suggesting that these cells play a role in the generation of abnormal sensory mechanisms. The persistent change that takes place in these FIC cell types during long-term culture has given us a different perspective suggesting the probability of multiple changes along the sensory pathway. Recent findings support an important role for activation of spinal cord glial cells in both initiation and amplification of persistent pain, as it is known that these cells can enhance and prolong the response of second order spinal sensory neurons to peripheral stimulation. Thus, multiple sites in the sensory pathway may have a similar type of 'primary' defect, or a primary defect in the urothelium may sequentially trigger a secondary defect at more proximal sites. Our goals in this renewal application are to further understand the signaling pathways underlying the persistent changes observed in urothelial (and glial cell) function, as well as signaling mechanisms responsible for various cell-cell interactions and how these mechanisms may be altered in FIC. These goals will be accomplished using a multidisciplinary approach including imaging techniques, molecular biology and measurement of transmitter release. Aim #1 will evaluate intracellular mechanisms regulating urothelial vesicle recycling and transmitter release in PBS/FIC. We hypothesize that the release of mediators/signaling factors from the urothelium in response to mechanical or chemical stimuli contributes to the sensory symptoms in cats diagnosed with FIC. This aim will utilize imaging with membrane-impermeant dyes in order to explore the mechanisms responsible for chemical and mechanical evoked release of mediators from urothelial cells. Aim #2 will evaluate mechanisms underlying changes in umbrella cell morphology, signaling and communication in PBS/FIC. We will use intact bladder sheets and polarized urothelial cultures to measure changes in apical cell properties and cell signaling between urothelial layers. Aim #3 will evaluate morphological/functional properties of spinal cord glial cells in PBS/FIC. We will characterize the chemistry/morphology and function of cultured spinal cord astrocytes as well as glial-neuronal interactions in normal and FIC. Understanding the mechanisms involved in these types of changes may provide important insights for the development of novel targets for the clinical management of PBS/IC.

Public health relevance
PUBLIC HEALTH RELEVANCE: Painful Bladder Syndrome/Interstitial Cystitis (PBS/IC) is a chronic, idiopathic painful condition of the urinary bladder which is often described as a disease of the urothelium (the epithelial layer lining the bladder lumen). A comparable disease in cats, termed feline interstitial cystitis (FIC), exhibits nearly all of the characteristics and symptoms to that of human PBS/IC. This is a renewal application of a grant where we determined that FIC-urothelium exhibits a heightened sensitivity to chemical and physical stimuli with subsequent augmentation of urothelial-derived transmitter release. These studies will examine mechanisms underlying this type of nonneuronal allodynia/hyperalgesia. Understanding the mechanisms contributing to and maintaining these types of changes may provide important insight for the identification of novel targets for the future clinical management of bladder diseases such as PBS/IC. NARRATIVE Painful Bladder Syndrome/Interstitial Cystitis (PBS/IC) is a chronic, idiopathic painful condition of the urinary bladder which is often described as a disease of the urothelium (the epithelial layer lining the bladder lumen). A comparable disease in cats, termed feline interstitial cystitis (FIC), exhibits nearly all of the characteristics and symptoms to that of human PBS/IC. This is a renewal application of a grant where we determined that FIC-urothelium exhibits a heightened sensitivity to chemical and physical stimuli with subsequent augmentation of urothelial-derived transmitter release. These studies will examine mechanisms underlying this type of non- neuronal allodynia/hyperalgesia. Understanding the mechanisms contributing to and maintaining these types of changes may provide important insight for the identification of novel targets for the future clinical management of bladder diseases such as PBS/IC. __SpecificAimsTextDelimiter__ Specific Aims Introduction. This funding period (to date, 3.5 years; 4 years total funding) has resulted in a significant body of data indicating that an animal model for PBS/IC, feline interstitial cystitis (FIC), which exhibits similarities to this disorder in humans, exhibits changes in morphology and function in both neural as well as non-neuronal cells. Many of these findings: a) have been published (noted as bracketed/italicized in the progress report), b) still in progress during this last year of the funding period, or are c) preliminary findings supporting new and expanded research directions. These data include: (1) FIC alters sensor, transducer and barrier function properties of urothelial (UT) cells, 2) FIC alters properties of bladder afferents (morphological and electrical characteristics), 3) FIC is associated with alterations in bladder cell-cell communication, which originates in the urothelium and 4) FIC is associated with alterations of spinal cord non-neuronal (glial) cells in regions of pelvic afferent input. Because many of these changes have been detected in vivo and persist in cells maintained in culture, we hypothesize that either primary abnormalities occur simultaneously in multiple cell types or that pathophysiology at one site (e.g. UT) can induce long term changes at other and more distant sites along the sensory pathway from the bladder to the brain. Available evidence has revealed that functional pain syndromes such as PBS/IC (often described as a disease of the epithelium) are associated with increased sensitivity to both physical and chemical stimulation. Increasing evidence supports a role for spinal cord glial cells in the modulation of sensory-neuronal processing. Taken together our findings support our overall hypothesis that persistent changes in FIC urothelial (and glial) cells including a heightened sensitivity to both chemical and physical stimulation may be in part due to changes in intracellular Ca2+ release/sequestration and/or intracellular signaling pathways. In this regard, increased urothelial sensitivity could lead to changes in activity in pelvic pathways, activation of spinal cord neurons and glial cells with associated pain. In the proposed studies we will examine the signaling mechanisms underlying these FIC-resultant alterations in the following aims: 1. Specific Aim I will evaluate intracellular mechanisms regulating urothelial vesicle recycling and transmitter release in PBS/FIC. 2. Specific Aim II will evaluate mechanisms underlying changes in umbrella cell morphology, signaling and communication in PBS/FIC. 3. Specific Aim III will evaluate morphological/functional properties of spinal cord glial cells in PBS/FIC.